CORE--PROTOCOL REVIEW AND MONITORING SYSTEM (PRMS)

The PRMS is critically important for the quality control of studies undertaken within the Cancer Center. The PRMS coordinates internal peer review and quality control functions for all Columbia-Presbyterian Medical Center protocols that involve cancer patients. The PRMS is currently housed in newly constructed space in the Milstein Hospital Building (MHB 6N-435) convenient to both inpatient and outpatient units.